Salivary Protein Influence on Taste and Feeding

Project Summary
Taste perception plays a key role in diet selection. Although bitter compounds are often associated with toxic
substances, a large number of nutritionally significant food sources contain bitter phytochemicals (e.g.,
broccoli, spinach). Understanding how bitter taste is perceived and detected is of great importance for
increasing the acceptability of pediatric medicines and may assist in efforts to promote healthy eating in
children and adults. Under normal feeding and drinking conditions, taste compounds mix with saliva before
reaching their receptor targets. Little is known about how the proteins in saliva interact with taste stimuli and
alter bitter taste perception. Salivary protein composition changes with exposure to bitter diets (the induction
phase) and in turn alters the behavior of animals consuming bitter diets by increasing the acceptability of their
taste (the increased acceptance phase). Although there is a strong link between bitter diets and salivary
protein (SP) expression, the physiological mechanisms underlying these linkages are unknown Specific Aim 1
will examine the induction phase by examining the role of taste in the upregulation of SPs. Specific
Aims 2 and 3 will examine the increased acceptance phase. We hypothesize that SPs will diminish taste-
mediated responses at two levels of organization: 1) immediate behavioral responses, as assessed by taste
reactivity tests; 2) calcium responses of isolated taste cells to chemical stimuli. Specific Aim 4 will examine
the role of SP profile in diet acceptance. We hypothesize that diets that induce similar patterns of
expression will increase acceptance of each other, while diets with different patterns will not. These
experiments will allow us to identify which proteins are important for the increased acceptance of bitter diets.

Public health relevance
Project Narrative Understanding how bitter taste is perceived and detected is of great importance to understanding diet selection. A large number of nutritionally significant food sources contain bitter phytochemicals many of which can have medicinal value and pediatric medicines are often rejected due to the bitter taste. Salivary proteins increase the acceptability of bitters, therefore understanding the role of salivary proteins in taste perception may assist in efforts to promote healthy eating in children and adults, and guide development of more effective artificial saliva products and oral treatments for chemotherapy patients with taste distortions.